Core D: Data Analysis Core

Project Summary – Core D (Data Analysis Core)
The Data Analysis Core (DAC) will build on available computational infrastructure to fulfill all the needs for
advanced data analysis and informatics of the Yale SenNet TMC. It will also provide support for data storage
and sharing, metadata management and referencing, web-based data portable and query, and rigorous
statistical analyses to accomplish the center’s missions. The DAC will be led by Dr. Yuval Kluger, who provides
prominent expertise bioinformatics and computational analysis of multi-dimensional data including sequencing
and imaging data. He has an extensive track record of methodology development and collaborative work in
studies analyzing data generated by genomics and proteomics technologies in major NIH consortia. Co-I
Gershkovich is directing Yale Clinical Pathology data infrastructure and management. He will provide prominent
expertise in building pipelines, frameworks and portals for integrating biospecimen metadata with biological
analysis data from multiple modalities including omics and images. He will develop a workflow tracking system
for specimen collection, annotation, analytic data, and sharing. The DAC will develop pipelines to analyze data
from 4 assay modalities in the Biological Analysis Core (BAC). Specifically, the DAC will carry out the key
functions for (1) data processing – to set up a set of multiscale and multimodal data processing pipelines and
quality assurance protocols, (2) data analysis – to establish an integrated single-cell & spatial data analysis
workflow and biomarker signature inference, (3) map construction – to construct tissue molecular and cellular
maps via image co-registration and multi-omics co-referencing, and (4) consortium coordination – to work with
the CODCC and other TMCs to develop common database, visualization, and query. The DAC will generate the
Molecular Maps and Cellular Maps of cellular senescence in human lymphoid organs, define cell type-specific
senescence biomarkers, dissect senescent cell heterogeneity, and delineate the interactions with senescence-
associated tissue environments. It will also assemble data standards, facilitate dissemination, and integrate our
data with existing or newly generated atlases and maps from SenNet and other NIH Consortia. These are highly
valuable next-generation biomedical data resources for a broad community of basic, translational, and clinical
research.